CORE C: CLINICAL AND BIOSTATISTICS CORE

To support the research goals of our CCHI, the Clinical and Biostatistical Core proposes to continue long-term
follow up of our established COVID-19 cohort of 747 patients over the next 5-year grant cycle. The unique
features of COVID-19 immunity can be explored in this cohort, which presents an incredible opportunity to
advance mechanistic insight into the induction of innate and adaptive immunity to a novel, highly transmissible
pathogen that poses ongoing threats to human health. Knowledge gained from these immunological studies
can inform approaches to control future emerging human coronaviruses that could become major public health
concerns. The Specific Aims of the Clinical Core are: Aim 1. Provide the clinical infrastructure and expertise for
conducting human research to improve mechanistic understanding of immunity following vaccination and
infection among different age groups. Aim 2. Define immune memory in study participants enrolled in our
COVID-19 longitudinal cohort who recover or experience Long COVID. Aim 3. Provide statistical, modeling, and
data management expertise that ensures the success of the CCHI scientific agenda

Public health relevance
The Clinical/statistical Core remains a vital component of the Emory CCHI program and continues to support the CCHI scientific agenda for over 15 years. The clinical units of the Core will manage the Covid-19 cohort and support the projects providing sample collection to support the CCHI scientific agenda.